Exploring Neuronal Subtype-specific Mechanisms of Ethanol Dependence and Reward: Contributions of Voltage-gated Potassium Channels

Project Summary/ Abstract
Individuals with alcohol use disorder (AUD) show deficits in cognitive function and an inability to regulate ethanol
consumption and seeking. These deficits are driven by medial prefrontal cortex (mPFC) dysfunction. Ethanol
dependence induced by chronic intermittent ethanol (CIE) vapor exposure disrupts expression of mPFC Kcnc1.
This gene encodes voltage-dependent KV3.1 potassium channels, which are highly enriched in parvalbumin
positive fast-spiking interneurons (PV+FSIs). Our preliminary data show that CIE-induced dysregulation of mPFC
PV+FSI activity is restored by a novel KV3 channel positive modulator which also reduced drinking in dependent
and non-dependent mice. These data implicate aberrant KV3 channel activity in PV+FSIs with dependence-
induced deficits in mPFC function. We hypothesize that dependence-induced excessive drinking, ethanol
reinforcement, and cue-induced relapse-like behavior are regulated by disruption of mPFC KV3 channel activity
in PV+FSIs. Specific Aim 1 will examine functional neuroadaptations of KV3 channel activity in mPFC PV+FSIs
of G42 (PV-GFP) transgenic mice exposed to CIE or Air, and test the effects of KV3 positive modulators to
restore dependence-induced adaptations in PV+FSI function. We will also test if reduced KV3 channel
expression is an underlying cellular mechanism driving aberrant KV3 channel activity in PV+FSIs. Specific Aim
2 will test if enhancing KV3 channel activity in the mPFC will reduce ethanol consumption in CIE and Air-exposed
mice during home cage drinking sessions. Studies will also determine if KV3 positive modulation can restore
mPFC PV+FSI activity during home cage drinking sessions in PV-Cre mice using in vivo fiber photometry
techniques. Specific Aim 3 (R00 phase) will shift from studying home cage drinking to studying the role of mPFC
KV3 channels in regulating the reinforcing effects of ethanol and relapse-like behavior by using operant
conditioning procedures in dependent and non-dependent rats. Using in vivo fiber photometry, studies will test if
positive modulation of KV3 increases Ca2+ transients in PV+FSIs in CIE-exposed PV-Cre rats, and in turn,
decreases motivation to self-administer ethanol. Experiments will also determine if enhanced KV3 activity
reduces ethanol-seeking behavior and modifies Ca2+ transients in PV+FSIs during cue-induced reinstatement
tests in CIE-exposed PV-Cre rats. Collectively, these studies will validate KV3 channels as a novel target for the
development of effective treatment options for ethanol dependence. In addition, the proposed experiments will
provide training in emerging techniques used to selectively measure cellular function in sub-populations of
cortical neurons of behaving transgenic animals.

Public health relevance
Project Narrative Individuals that are dependent on alcohol drink to excess and display life-threatening physical withdrawal symptoms that increase the risk for relapse during treatment. The current research project will explore changes in brain function as a result of the development of alcohol dependence and will test new compounds to reduce excessive drinking in dependent animal models. The proposed experiments will provide insight into the cellular properties that control the development of alcohol dependence and heavy drinking.